Full Sail Ahead: How Membranes Move and Respond to Flow

PROJECT SUMMARY
A remarkable feature of lipid membranes is their fluidity: they can self-heal, bend, and circulate.
Individual cells also experience and respond to the flows in their environment. Flow responses regulate diverse
processes such as blood pressure, bone density, and neural growth. This is particularly apparent in blood
vessels, where a monolayer of endothelial cells forms the interface between flowing blood and stationary
tissue. Correlation between regions of low flow and atherosclerotic plaques was observed a century ago,
leading to the hypothesis that shear flow impacts endothelial cell function. Understanding how cells accomplish
mechanotransduction of shear stress into cellular signals is of wide interest. However, the molecular
determinants behind flow mechanotransduction remain unclear. Particularly, we lack information on the lateral
movement of extracellular membrane proteins located at the cell-fluid interface. While flow has been observed
to transport membrane proteins, how this transport affects protein function and cell responses remains
unknown.
The goal of the proposed studies is to quantitatively measure the physical interactions specific to lipid
membranes that determine how lipids and proteins move in response to flow and test whether flow transport of
a membrane protein activates intracellular signaling in endothelial cells. Our central hypothesis is that
physiologically significant protein and lipid concentration gradients arise from physical interactions between
fluid flow and complex membranes. This hypothesis is based on the premise that extracellular lipid-anchored
proteoglycans like glypican-1 can be transported along the plasma membrane by external flow, with the
aqueous part of the protein acting as a molecular sail. We will accomplish three specific aims: Our first aim is
to identify the fundamental properties and principles that govern flow transport of membrane-linked proteins in
model membranes and to build a model to predict protein motion in physiological contexts. In the second aim,
we will determine how the flow-mediated lateral transport of a physiologically important membrane protein
(glypican-1) initiates the short-term flow response in endothelial cells. In our third aim, we will investigate how
lipid sorting by flow contributes to flow signaling in our model system and living cell membranes.
Our approach is to conduct parallel experiments in model membranes and living cells, allowing us to
directly relate physiological function to molecular biophysics. The experiments rely on the PI's expertise using
experimental microfluidics and confocal microscopy to determine fundamental membrane properties. While the
model protein studied here is specific to endothelial cells, the principles of fluid mechanics that we will uncover
are universal. We, therefore, anticipate that our models will apply to multiple cell lines and flow conditions, and
will lay the groundwork for future research directions.

Public health relevance
PROJECT NARRATIVE This project is relevant to human health because cells detect and respond to flow in order to regulate cardiovascular health, neural growth, and angiogenesis in development and in cancer. The proposed research will determine how fundamental fluid mechanics and membrane biophysics contribute to flow sensing in cells. This work will contribute to the part of the NIH's mission that seeks to understand general principles that underly biological functions.